Quantitative Magnetization Transfer Imaging for Early Detection of Alzheimer's Disease

Project Summary
Alzheimer's disease (AD) is the most common cause of dementia and, at present, an irreversible neurode-
generative disease with an ever-increasing disease burden in the United States. Clinical management and de-
velopment of novel therapeutics for AD will beneﬁt from reproducible, robust and non-invasive markers of early in
vivo AD pathology, but no such tools are well-established in routine clinical practice. Quantitative magnetization
transfer (qMT) is an MRI based technique for detecting microstructural tissue changes such as demyelination and
the presence of macromolecules, including amyloid beta protein. This sensitivity to multiple aspects of the amy-
loid/tau/neurodegeneration framework offers a promising diagnostic alternative to amyloid PET in a single, rapid
and high-resolution imaging exam. My preliminary ﬁndings suggest that, using the theory of hybrid state free
precession developed in my research group, qMT images can be acquired in vivo in 12 minutes at 1mm isotropic
resolution with good SNR. Additionally, by direct comparison to PET in a cognitively normal but amyloid positive
subject, qMT appears to be sensitive to the early accumulation of amyloid beta and conﬁrms previous literature
reports of increased qMT exchange rates in AD. My proposal aims to solve the remaining technical challenges
surrounding qMT by optimizing the acquisition for improved sensitivity to amyloid beta (Aim 1) and developing
a neural network based reconstruction pipeline to substantially reduce the post-processing time and improve its
robustness to magnetic ﬁeld inhomogeneities (Aim 2), which create biases in the quantitative parameters. These
biases are particularly important to curtail in the deep brain, where the accumulation of amyloid beta is purported
to begin in AD. In Aim 3, I will perform a pilot study to compare the proposed qMT method's sensitivity for in
vivo amyloid beta in a cognitively normal population directly to amyloid PET. Together, this will establish qMT as a
surrogate marker for in vivo amyloid and motivate further clinical studies on its utility in monitoring AD progression
and response to therapy.

Public health relevance
Project Narrative This project aims to develop a rapid and robust quantitative magnetization transfer imaging method sensitive to early in vivo amyloid beta pathology in cognitively normal individuals. This innovation is enabled by the use of two key technologies: the hybrid spin-ensemble state and unrolled neural networks. Successful completion of this project will establish quantitative magnetization transfer as a viable technique for tracking Alzheimer's disease progression and monitor patient's responses to novel drug therapies.